Core G: Research Education Core

RESEARCH EDUCATION COMPONENT - SUMMARY/ABSTRACT
The overarching goal of the Research Education Component (REC) of the Shiley-Marcos Alzheimer’s
Disease Research Center (ADRC) at UC San Diego is to support the research education and mentoring of
outstanding junior-level scientists (defined as advanced postdoctoral fellows and assistant professors) to
advance our understanding of the complex and heterogenous nature of Alzheimer’s disease and related
dementias (ADRD). To realize this goal the Shiley-Marcos ADRC REC (1) has developed a detailed
recruitment plan to recruit a diverse cadre of outstanding trainees to the program each year, (2) will provide a
solid foundational platform to prepare this diverse research workforce with transdisciplinary expertise and
ability, and (3) engage our trainees and their mentors in the team science initiatives necessary to meet the
ambitious goals of the National Plan to address Alzheimer's Disease to prevent and treat ADRD.
The REC specific aims are to: 1) Develop the careers of advanced research associates and junior faculty
who demonstrate outstanding research potential and an interest in research focused on understanding factors
that affect the heterogeneity, etiology and outcomes in ADRD; and 2) Provide mentorship, education, career
development activities and a broad array of educational and infrastructural resources across the multiple sites
afforded by our rich academic and clinical settings (e.g., School of Medicine, main campus, VA, and affiliated
institutions such as the Salk Institute for Biological Studies) to enable our REC scholars to enhance their
expertise in ADRD research and research methods, successfully complete their research, present and publish
their work, and attain independent research and/or career development funding.
The Shiley-Marcos ADRC REC program will be directed by two Leaders and one Consultant from UC San
Diego: Lead Dr Bondi (UCSD – Psychiatry; VA – Psychology / Neuropsychology), Co-Lead Dr Hook (UCSD -
Pharmaceutical Sciences, Neurosciences, and Pharmacology), and Consultant Dr Moore (UCSD – Medicine /
Geriatrics; PI UCSD/SDSU AD-RCMAR). The Leaders and Consultant have complementary scientific skills
(e.g., basic vs. clinical science), reside in multiple campus localities, and have collaborated to develop this
program using the team science model. With Dr Moore we will coordinate selection of our REC scholars with
that of the AD-RCMAR to maximize our breadth and depth of trainee support from these two programs. The
Program Faculty have been assembled with the goals of diversity with respect to their disciplines, research,
advanced mentoring skills, and affiliations. The REC Leaders and Consultant will continuously and objectively
monitor the effectiveness of the training program, dynamically modifying the program based on feedback from
mentors, mentees, and ADRC Executive Committee, to provide the highest quality training program possible.